Reducing parental substance use, improving child health outcomes, and enhancing family resilience among rural families through Ohio START (Sobriety, Treatment, and Reducing Trauma)

PROJECT SUMMARY/ ABSTRACT
Co-occurring parental substance use disorder and child maltreatment are key risk factors associated with
health inequities and disparities among children and families in rural areas. Importantly, rural communities face
geographic, economic, and social barriers that limit their access to high-quality healthcare resources and
services, exacerbating health disparities. Ohio Sobriety, Treatment, and Reducing Trauma (Ohio START) is a
family-centered child welfare service delivery intervention that builds on cross-system collaboration with
behavioral health service organizations to provide timely access to behavioral health services for families
involved with the child welfare system. Ohio START also supports parents’ journey to recovery through peer
mentors with lived experience in substance use recovery and previous child welfare involvement. Ohio START,
while promising, has not been rigorously studied to determine how it modifies parents’ spatial and social
environments to reduce parental substance use and improve child health outcomes in rural communities. It is
also unclear how parents experiencing economic disadvantage change their spatial and social environments in
rural communities where there are fewer service resources. These are important questions that, if answered,
could enhance interventions to better serve socioeconomically disadvantaged families in rural communities.
Capitalizing on unique opportunity to leverage the ongoing Ohio START initiative and access child welfare–
involved families in rural areas, we seek to collect novel, longitudinal activity space and social networks data
from 400 families engaging in Ohio START. The study has three specific aims: (1) To determine whether the
proximity and availability of behavioral health providers in child welfare workers’ referral networks from parental
activity spaces predicts intermediate and long-term family health outcomes. (2) To examine how Ohio START
family peer mentoring services affect attributes of parental activity spaces and social networks and family
resilience over time, and how these changes are associated with long-term family health outcomes. (3) To test
whether rurality moderates the effects of activity spaces, behavioral health services referral networks, and
social networks on intermediate and long-term family health outcomes. The study aims directly address one of
the NICHD’s research priorities “Understanding Social Determinants of Health and Developmentally Informed
Strategies to Mitigate Health Disparities.” The proposed project will produce valuable knowledge that can be
used to modify START and other family-level intervention efforts to mitigate risks and maximize protection in
parents’ spatial and social networks to enhance family resilience, prevent child maltreatment, and promote
child well-being in socioeconomically disadvantaged rural communities.

Public health relevance
PROJECT NARRATIVE The proposed project will examine how a family-centered intervention model Ohio Sobriety, Treatment, and Reducing Trauma (Ohio START) may lead to improved child and family health outcomes for socioeconomically disadvantaged rural families by altering parental spatial and social environments through formal (e.g., substance use disorder treatment services) and informal (e.g., positive social networks) supports. This proposal will give particular attention to the role of rurality in moderating these pathways to elucidate key factors and mechanisms associated with rural health disparities. The proposed study has the potential for high public health impact because study findings will inform novel place- and network-based intervention efforts to strengthen formal and informal support systems and enhance family resilience and child well-being in socioeconomically disadvantaged rural communities.